Ultrasensitive Point of Care Antigen Test for Detection of Neisseria Gonorrhoeae Using Plasmonic Flours

Project Summary/Abstract:
An antigen test for Neisseria gonorrhoeae (Ng) that is accurate, simple, scalable, non-invasive, rapid, and
effective at the point-of-care (POC), would transform public health decisions. Although antigen detection rapid
diagnostic tests (Ag-RDT's) for Ng are available, they have poor sensitivity (50% or less) compared to gold
standard nucleic acid amplification tests (NAAT). A NAAT based POC test was recently cleared by the US FDA,
however its use in resource-poor settings is limited by its high cost. To overcome these barriers for the first time,
we will harness ultrabright fluorescent nanoconstructs, called plasmonic-fluors, a recent breakthrough from our
labs that enables such antigen testing with sensitivity that matches NAATs. The objective of this proposal is to
develop an ultrasensitive plasmon-enhanced lateral flow assay (p-LFA) that detects the lipoprotein H.8 antigen
present on Ng surface. The rationale underlying this proposal is that a highly sensitive Ag-RDT that can match
the accuracy of NAAT could meet the critical need for diagnosing Ng infection at the POC and in resource-limited
settings. We will achieve this by pursuing two specific aims: 1) Develop and optimize the p-LFA for detecting
Ng lipoprotein H.8 antigen in urine samples obtained from healthy people. 2) Determine the diagnostic accuracy
of the Ng antigen test compared to gold standard NAAT in urine specimens from patients with suspected Ng
infection. The proposed approach is innovative in that it harnesses plasmonic-fluor as a fluorescent nanolabel in
a LFA as opposed to the conventional gold nanoparticles, which provide only a weak colorimetric signal. With
over 1000-fold improvement in sensitivity, this approach has the potential to transform antigen testing. The
proposed research is significant as the novel p-LFA will meet the critical needs for widespread Ng testing
scalability, speed, and low cost. The expected outcome of this work is a simple, non-invasive, Ag- RDT for Ng
infection, implemented as a LFA that can replace NAAT by virtue of its accuracy and low cost in resource-limited
settings. This test will have a tremendous positive impact immediately as it will be applicable to large scale Ng
testing with an inexpensive test strip and minimal battery-powered portable equipment, without relying on skilled
personnel. Furthermore, this test will serve as a prototype for ultrasensitive antigen tests applicable to many
other infectious diseases in addition to the possibility of incorporating multiple antigens on a LFA for diagnosing
other sexually transmitted infections such as chlamydia and trichomoniasis in addition to Ng.

Public health relevance
Project Narrative Section We will harness a recent breakthrough in plasmon-enhanced fluorescence technology to create a new antigen test for Neisseria gonorrhoeae (Ng) that is as accurate and reproducible as gold standard nucleic acid amplification tests, but one that is cheaper, faster, and simpler. We will verify the efficacy of Ng antigen test by utilizing remnant urine samples from patients with suspected Ng infection. If successful, this test will have a tremendous positive impact immediately as it will transform the diagnostic landscape for Ng testing by its scalability with an inexpensive test strip and minimal battery-powered portable equipment, without relying on skilled personnel.